Core A: Administrative Core- Admin and Clinical Core

ABSTRACT
Frontotemporal dementia represents a group of clinical syndromes that specifically target language, behavior,
social, and motor systems. The overarching goals of this Program Project Grant have been to detail the
pathologic, genetic, imaging, cognitive, emotional, and behavioral features of these syndromes. In this renewal
application, the Administrative and Clinical Core continues to maintain the PPG's overall administrative
infrastructure and provide well characterized subjects and biospecimens to the PPG Projects and other Cores.
Our specific aims are to recruit patients with bvFTD (n=90), svPPA (n=40), nfvPPA (n=30), lvPPA (n=30), non-
language AD (n=30), CBS/PSP (n=30), asymptomatic mutation carriers (n=20), major depressive disorder
(n=100), bipolar disease (n=100), and normal controls (n=15), engage in deep behavioral phenotyping, follow
subjects annually, obtain autopsy consent, integrate evaluation data with the Imaging, Genetics, and
Neuropathology/Biospecimen Cores, and refer subjects to the individual, hypothesis-driven PPG Projects.

Public health relevance
PROJECT NARRATIVE The overarching goals of this Program Project Grant are to further detail the pathologic, genetic, imaging, cognitive, emotional, and behavioral features of the frontotemporal dementias. Project goals include providing tools for better differential diagnosis, understanding disease progression along anatomical networks, and defining non-language changes in the progressive aphasia. The aims of this Administrative and Clinic Core are to recruit and evaluate subjects, refer subjects to the Projects and other Cores, and provide the overall PPG scientific, administrative and budgetary infrastructure.